ITCA Capacity Building: Developing the Arizona Tribal Research Review

NARCH XI Capacity Building Project Abstract
The cultural differences of conducting research within the American Indian/Alaska Native communities is
becoming a greater concern of ethical and moral approach. A large number of researchers from institutions is
vastly increasing with greater interest. However, an ethical approach to research conducted on tribal land is
important from implementing a project, collecting the data and data sharing. The American Indian people are
culturally connected to with an Indigenous framework of one’s self as a whole especially during research. The
historical cases of mistrust of research from non-community members has promoted negative publications and
promote stereotypes of AI/AN. The Belmont Report created in 1974 prompted the Indian Health Service to
establish Institutional Review Board or other forms of research committees. Several Tribes have created IRBs;
smaller tribes do not have the resources nor opportunity. As each tribal government is organized differently,
the Inter Tribal Council of Arizona, Inc. (ITCA), goal is to serve as the Institutional Review Board for Member
Tribes ensuring the research purpose is appropriate for the protecting and benefit for the tribal members and
tribal communities. ITCA has developed a strong relationship with Member Tribes in addition to creating
partnerships with research institutions. The purpose of the capacity building project, “Developing the Arizona
ITCA Tribal Research Review Board” is to address the concern in creating a research review board to ensure
member tribal communities are assisted in providing protection and guidance with thought of benefits of all
research presented to the community.
Specific Aims. We will:
1. A consultation with ITCA Member Tribes and The University of Arizona partnership will develop a Tribal
Research Coalition to review policies, and procedures, along with agreements, and protocols align with
data sovereignty rights.
2. Establish a Tribal Institutional Review Board (IRB) consisting of members of Tribal leadership and
voluntary committee members collaborating within research institutions providing guidance on research
ethics to ensure tribal members and tribal community benefit from research projects in an ethical approach
serving ITCA Member Tribes who do not have an institutionalized IRB process within the tribal government.
3. Collaborate with The University of Arizona to create training workshops for tribal and non-tribal members
who acknowledge interest in conducting tribal research with any ITCA Member Tribe to increase culturally
appropriate awareness and ethical research respecting tribal sovereignty.

Public health relevance
NARCH XI: AIRCH Developing the Arizona Tribal Research Review Board Capacity Building Project Narrative The cultural differences of conducting research within the American Indian/Alaska Native communities is becoming a greater concern of ethical and moral approach. A large number of researchers from institutions is vastly increasing with greater interest. However, an ethical approach to research conducted on tribal land is important from implementing a project, collecting the data and data sharing. The American Indian people are culturally connected to with an Indigenous framework of one’s self as a whole especially during research. The historical cases of mistrust of research from non-community members has promoted negative publications and promote stereotypes of AI/AN. The Belmont Report created in 1974 prompted the Indian Health Service to establish Institutional Review Board or other forms of research committees. Several Tribes have created IRBs; smaller tribes do not have the resources nor opportunity. As each tribal government is organized differently, the Inter Tribal Council of Arizona, Inc., goal is to serve as the Institutional Review Board for Member Tribes ensuring the research purpose is appropriate for the protecting and benefit for the tribal members and tribal communities. ITCA has developed a strong relationship with Member Tribes in addition to creating partnerships with research institutions.